Administrative Core A - Research Administration

The CCSB has organized a leadership structure to provide expertise and fully support all initiatives. The leadership consists of the Principal Investigator, Chris Sander, PhD. Support personnel consists of the CCSB Research Director (TBN) and a staff assistant (TBN). The CCSB leadership and support personnel, also known as the Administration, will work collectively to support and accomplish the proposed research projects, core, educational and training unit, outreach and dissemination unit, and pilot and trans-network projects. The staff of the CCSB Administration will provide the organizational support and leadership to permit the research projects and core to accomplish their goals and to distribute the accomplishments of each CCSB lab among the CCSB investigators and around the world. Achieving this goal requires rapid and precise analysis of research data followed quickly by its dissemination to research team members and the scientific community. The CCSB Administration will work closely with CCSB investigators to achieve this latter objective. It will also provide budgetary review and scientific oversight. The CCSB Research Director, working with the Principal Investigator, will prepare and distribute a yearly progress report for the EAP to assist in their annual review and oversight. The CCSB Steering Committee will meet annually and will consist of one investigator from each CCSB. The Principal Investigator, Dr. Chris Sander, will represent our CCSB at the Steering Committee Meeting.